New Nanoprobes for MR Imaging of TrkB in Alzheimer's Disease

Alzheimer's disease (AD) is a chronic and disabling brain disease characterized by amyloid beta (Aβ) and tau
accumulation, and progressive loss of synapses and neurons that are associated with low brain-derived
neurotrophic factor (BDNF) and tropomyosin receptor kinase B (TrkB) levels. Recent studies show deficient
BDNF-TrkB signaling mediates amyloid-β and tau induced neurotoxicity, reduced neurogenesis, synaptic
dysfunction, and memory deficits in AD. Also, BDNF and TrkB hippocampal (HIP) gene expressions are
predictors of neuritic plaque and neurofibrillary tangle pathology. Postmortem studies showed decreased HIP
levels of TrkB in AD patients that correlated with their cognitive performance and neuropathology. Thus, early
detection of decreased TrkB expression; which is implicated in impaired neurogenesis, synaptic damage and
neuronal death; is critical for the rapid prevention and treatment of AD. New TrkB radioligands are currently
being developed for PET but they are not specific for TrkB and cannot easily cross the BBB. Positron emission
tomography (PET) has high sensitivity for receptor imaging but is limited by low spatial resolution and the
limited availability of PET techniques. This application's goal is to develop non-radioactive nanoprobes that
can be used for imaging of TrkB with conventional MRI scanners that are available in many more clinical
settings than PET.
A two-part TrkB-targeted nanoprobe (TNP<100 nm) will be designed. One part is a protein carrier containing a
widely used MRI gadolinium contrast agent (Vitaliano at al. 2012). ExQor's patented nanocarrier is constructed
out of clathrin, a naturally occurring protein the body uses for transporting materials inside cells. The second
component will be the mature form of BDNF (mBDNF) that binds with high affinity and specificity to TrkB.
mBDNF will be attached to the clathrin carrier by polyethylene glycol (PEG) molecules. In Phase 1 of the SBIR,
a series of studies will ascertain NP uniformity and stability, plus NP affinity and specificity for TrkB in vitro
and in vivo. In Phase 2, the feasibility of this MRI tool to detect TrkB expression and track progression of the
disease will be demonstrated ex vivo and in vivo in a mouse model of AD. We expect to detect early decreases
in TrkB associated with impaired HIP neurogenesis before Aβ/tau pathology. We also expect to show the
stepwise lowering of HIP CA1 TrkB with progression of the disease that is associated with Aβ and tau
accumulations, and synaptic and neuronal damage.
Especially important for patients with AD, the new non-radioactive NPs may be used for early diagnosis of AD
and regular monitoring of disease progression and the recovery process. This project may provide
tools/techniques for molecular brain imaging that could have similar sensitivity to PET but can be used
repeatedly for biomarker detection in AD. The commercial significance is in filling an unmet medical need for
an imaging biomarker for early diagnosis of AD. This new nanotechnology may have utility as an agent to
predict susceptibility and resilience to AD, enhance diagnosis/prognosis and may help evaluate the
effectiveness of drugs aimed to treat AD.

Public health relevance
The development of high sensitivity, high resolution MRI molecular nanoprobes may provide a major new diagnostic and research tool for noninvasive imaging of neurotrophic receptors (e.g., TrkB) in Alzheimer's disease. This new nanotechnology may have utility as an agent to enhance early diagnosis and prognosis of disease, to monitor progression of AD and treatment efficacy, and may serve as a theranostic system that can specifically target neurotrophic receptors and deliver drugs to the brain.